Endothelial Vasoprotection by Hypothermia

Neonatal seizures lead to cerebrovascular disease that can produce lifelong neurological complications.
Preventing cerebral vascular dysfunction may translate into prevention of neonatal encephalopathy. We search
for interventions that prevent cerebral vascular injury caused by neonatal seizures. Our major focus is on
cerebral vascular endothelium, which is most vulnerable to oxidative damage associated with neonatal seizures.
In our previous NIH-funded studies, we have discovered the cerebroprotective role of heme oxygenase (HO)
that catalyzes the formation of gaseous mediator carbon monoxide (CO) from the heme substrate. The HO/CO
system provides a potent antioxidant defense mechanism in the neonatal cerebral circulation. Our exciting novel
preliminary data indicate that endothelial HO activity is upregulated my mild cooling, thus producing CO
elevation in cerebral microcirculation. Our preliminary findings also suggest that mild cooling reduces brain
oxidative stress and prevents oxidative injury to cerebrovascular endothelium. Furthermore, we, for the first
time, identified functional interaction between HO activation and the cold-sensing receptor TRPM8 expressed
in cerebral vascular endothelium. These novel findings provide a strong scientific premise to our mainstream
hypothesis that cooling provides endothelial vasoprotection by upregulating the HO-based antioxidant
defense via a mechanism that involves activation of the cold-sensing receptor TRPM8. We will test four
specific hypotheses using in vivo and in vitro approaches in newborn pigs, isolated cerebral vessels, and freshly
isolated and primary cultured cerebral microvascular endothelial cells: 1) Endothelial HO is activated by mild
cooling; 2) TRPM8 is critical for upregulation of endothelial HO by cooling; 3) Mild cooling promotes endothelial
survival during oxidative stress via the functional link between TRPM8 and HO; and 4) Head cooling during
seizures reduces oxidative stress and provides endothelial vasoprotection in the neonatal cerebral circulation.
We will use an exceptional combination of complementary techniques in a clinically relevant large animal
model of neonatal cerebrovascular disease. Such research is unique, as it combines functional and mechanistic
studies in intact cerebral circulation with investigation of the cellular and molecular mechanisms.
Pharmacological and gene silencing approaches in newborn piglets supplemented by the studies in TRPM8 KO
mice will be used to pinpoint causative functional relationships among cooling, TRPM8 activation, HO activity,
and endothelial functions in cerebral blood flow regulation and the blood-brain barrier integrity.
The proposed project uncovers novel fundamental temperature-sensitive mechanisms of anti-oxidant
cerebroprotection. This project may also have clinical implications for reducing debilitating effects of epileptic
seizures in the neonatal cerebral circulation. By protecting cerebral blood flow regulation and blood-brain barrier
integrity, head cooling may reduce neurological sequelae and improve the neurodevelopmental outcome of
seizures.

Public health relevance
The neonatal brain is very vulnerable to compromises in its blood supply. Cerebral vascular dysfunction caused by excessive production of reactive oxygen species during seizures in babies disrupts brain homeostasis and frequently produces lifelong complications. We are searching for novel mechanism-based approaches to neonatal cerebral vascular protection during oxidative stress to benefit the long-term outcome of neonatal seizures.